Wildland Urban Interface Exposure Toxicity in Cells, Animals, and Humans

ABSTRACT
Wildfires are a threat to public health worldwide, growing in both intensity and prevalence year-by-year,
particularly in regions at the Wildland Urban Interface (WUI). The health impacts associated with exposures to
wildfire smoke include those relevant to the pulmonary system, including asthma, bronchitis, dyspnea, chronic
obstructive pulmonary disease, and respiratory infections; however, the impacts and quantified health risks at
the WUI remain understudied. This research gap likely exists due to the inherent difficulties surrounding the
evaluation of these complex and variable atmospheric exposures. The team brought together by the PI has
established methods and recent data measuring harmful chemicals in simulated wildfire scenarios, including
conditions that incorporate anthropogenic materials indicative of the WUI environment. We have also
demonstrated through vigorous pilot experimentation that different wildfire smoke conditions converge upon
biological changes in the lung relevant to lung cell stress and hypoxia. Recent molecular-based experimentation
has also uncovered novel mediation of pulmonary toxicity through extracellular vesicle mechanisms coinciding
with incidences of cell stress and hypoxia. This study set out to test the innovative hypothesis that forest and
WUI burn scenarios will initiate MOAs with shared components across in vitro, in vivo animal, and human
systems, facilitating health risk predictions in humans for exposure conditions that need health guidances. We
will address this hypothesis through aims designed to carry out the following: First, we will use in vitro lung
models derived from human donors to evaluate biological responses across multiple forest and WUI-relevant
exposures, including conditions that are difficult to evaluate in vivo, particularly in humans due to feasibility
limitations and ethical considerations. Second, we will evaluate in vivo responses to select burn scenarios in
mice and humans, with analyses focusing on the prototypical burn scenario of smoldering red oak, without WUI-
relevant materials in humans and +/- WUI-relevant materials in mice. Biological responses that will be
characterized across systems include lung cell transcriptional and protein-level responses relevant to cell stress
and hypoxia, emphasizing hypoxia inducible factor 1 subunit alpha (HIF1A) and connected pathways. Functional
responses will include changes in lung function in vivo and markers of tissue injury/stress/inflammation.
Pulmonary secreted signals that are known to coincide with cell stress and hypoxia include extracellular vesicles,
which will also be evaluated for changes in physical characteristics, count, and molecular cargo. All aims
incorporate advanced computational toxicology approaches, paralleling strengths of the PI, and pave the way
for health risk estimates across a wide domain of wildfire exposures. This cross-cutting approach aligns with
many NIEHS goals and will serve as a solid foundation for the PI’s laboratory, to support future research efforts
aimed at improving environmental and public health.

Public health relevance
NARRATIVE Exposure to wildfire smoke is known to adversely impact the pulmonary system, though there remains an overall lack of knowledge surrounding the mechanisms and health risks across this highly variable exposure landscape of wildfire smoke, particularly within the expanding Wildland Urban Interface (WUI). This grant is designed to leverage the experimental strengths across in vitro, in vivo animal, and human systems to provide data needed for the health risk assessment of complex wildfire smoke mixtures. Findings will yield populations that are at heightened risks for health effects of wildfire smoke inhalation exposures based upon nearby fuel sources, and data will be used to effectively quantify these risks across difficult to study exposure scenarios that now require health guidances.